Molecular mechanisms of muscle stem cells transitioning intoquiescence

PROJECT SUMMARY The mammalian musculature provides mechanical force for locomotion. Muscles display remarkable ability to regenerate from reservoirs of muscle stem cells. How muscle stem cells transition from an actively proliferating population during development into a reserved population in adulthood for muscle repair/regeneration throughout lifetime is not known. I have obtained evidence that, in the mouse model, this process depends on the function of the Pax7 gene, which encodes a transcription factor. I plan the following aims to define 1) the precise role of Pax7, 2) the transcriptome changes during the development-to-adult transition, and 3) other essential genes (acting in parallel or downstream of Pax7) that mediate this transition. Aim 1: Determining the cellular and molecular defects of Pax7 mutant satellite cells. When and how do Pax7 mutant cells become defective in the development-to-adult transition? I will combine a plethora of assays for determining several muscle stem cell properties, including muscle differentiation, cell proliferation, cell death, niche occupancy, and cell polarity. These assays will be conducted with time course studies from newborn to adult. Aim 2: Performing mRNA-seq of Pax7 control and Pax7 mutant satellite cells. What are the transcriptome changes during this transition and what are the specific processes governed by Pax7? A comparative time course study of transcriptomes between control and Pax7 mutant cells throughout the development-to-adult transitional period will be performed using mRNA-seq, followed by bioinformatic analysis. Aim 3: Screening candidate genes for their function in satellite cells. What are the genes (in addition to Pax7) critical for the development-to-adult muscle stem cell transition? From Aim 2, I will select up to 50 genes to test for their function in this aspect; they may either act independently or downstream of Pax7. I will develop a novel assay for rapid screening of these genes' functions by combining gene knock-down and intramuscular transplantation of muscle stem cells.

Public health relevance
Project narrative: Muscle stem cells provide the replenishing source for muscle regeneration after injury. This proposal aims to determine the genes that control the genesis of muscle stem cells, using the mouse as a model. Results from this study will have clinical implications for stem cell based therapies of muscular dystrophies and of acute myotrauma from combat or accident. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Skeletal muscles provide the essential mechanical support for posture and movement. They have a remarkable ability to regenerate, a process that relies on a resident population of muscle stem cells, i.e. satellite cells1. The transcription factor Pax7 is specifically expressed in satellite cells and plays a crucial role in their molecular regulation as evidenced by a loss of satellite cells and severely compromised muscle regeneration in Pax7 germline mutant mice2-6. I have recently made the exciting discovery that the genetic requirement for Pax7 is temporally restricted to the first 2-3 weeks after birth6. This unexpected finding reveals that satellite cells undergo an intrinsic and critical genetic transition from a Pax7-dependent to a Pax7-independent state and as such acquire a new “genetic program”. This newly defined critical period is characterized by various cellular and molecular changes in satellite cells. My preliminary data indicate that during this early post-natal time window, satellite cells are directed to withdraw from myogenic differentiation and become quiescent (below, Aim 1). Pax7 mutant satellite cells fail to exit the myogenic differentiation program and display both cell polarity and niche occupancy defects (below, Aim 1), contributing to the loss of satellite cells. These data demonstrate the importance of the coordinated cellular and molecular changes orchestrated by Pax7 in satellite cells in order to produce a reserve muscle stem cell population for future use throughout life. Surprisingly, nothing is known about the molecular regulation driving these critical changes in satellite cells. I hypothesize that gradual transcriptional changes initiated by Pax7 direct satellite cells to become a quiescent reserve population of muscle stem cells. To test this hypothesis, I propose to define the molecular mechanisms that underlie this genetic transition of satellite cells in the aims below. Aim 1: Determining the cellular and molecular defects of Pax7 mutant satellite cells. I have generated a knock-in allele, Pax7CE, which expresses a tamoxifen-inducible Cre recombinase- estrogen receptor fusion protein, CreERT2, in place of Pax7, and which is therefore also null for Pax7. When combined with a Cre reporter allele, Pax7+/CE control and Pax7CE/CE mutant cells can be identified via reporter protein for additional assays. I will analyze Pax7 mutant satellite cells at critical early post-natal stages to adulthood (P0, P7, P14, P21 and P60) for myogenic differentiation, proliferation/quiescence, as well as cell polarity and niche occupancy. It is imperative for me to establish such a comprehensive framework for Pax7 control and Pax7 mutant satellite cells as such a systematic study for the cellular and molecular characteristics of satellite cells during this critical post-natal period is surprisingly lacking in the field. Results from this aim will provide highly pertinent information for studies in Aims 2 and 3. Aim 2: Performing mRNA-Seq of Pax7 control and Pax7 mutant satellite cells. I have combined the Pax7CE allele with a fluorescent Cre reporter allele, Rosa26YFP, which allows for isolation of a pure population of satellite cells by Fluorescent Activated Cell Sorting (FACS) from muscles of tamoxifen-treated Pax7+/CE;Rosa26YFP mice. I will isolate YFP+ cells from Pax7+/CE and Pax7CE/CE muscles at P0, P7, P14, P21 and P60 mice, as these time points represent a gradual transition from the Pax7- dependent to Pax7-independent state, as well as from a proliferative to a quiescent state. mRNA isolated from these sorted cells will be subjected to the illumina mRNA-Seq platform. The sequencing data will be interrogated on the basis of the framework established in Aim 1. This longitudinal study should identify genes and pathways that are coordinately regulated during the transition period, and define Pax7-regulated pathways. Aim 3: Screening candidate genes for their function in satellite cells. Select candidate genes will be tested functionally by transplantation of sorted neo-natal satellite cells expressing both mCherry and shRNA against the candidate gene (by lenti-viral transduction) into growing TA muscles of immuno-deficient mice. Transplanted satellite cells will be evaluated for their cellular and molecular behavior based on the assays established in Aim 1. My hypothesis predicts that the transcriptional network orchestrated by Pax7 regulates the production of a quiescent muscle stem cell reserve. As such, I will focus on genes which may directly regulate interactions with the local microenvironment including cell polarity, cell adhesion, extra-cellular matrix and signaling genes, as well as genes that exert epigenetic control.